Machine Learning-based Imaging Biomarkers for Metabolic and Age-related Diseases

Machine Learning-based Imaging Biomarkers for Metabolic and Age-related Diseases
Specific Aims
Age-related and metabolic diseases such as type-2 diabetes mellitus (T2DM),
cardiovascular disease (CVD), obesity, osteoporosis and sarcopenia have become a worldwide
epidemic that affects the quality of life of millions. To give a global perspective, roughly 343.8
million people in the world have type-2 diabetes today, and 175 million do not know they have diabetes at all. Metabolic
diseases, such as diabetes and obesity, are strongly linked to longitudinal changes in body composition, morphology and
function. Changes in skeletal muscle composition are strongly linked to loss in muscle strength and mass, frequently
termed as sarcopenia, leading to decreased mobility and function. The accumulation of adipose tissue in the human body
and changes of its regional distribution are associated with type-2 diabetes, cardiovascular disease and the metabolic
syndrome.
Contemporary imaging studies that are performed in vivo on a large number of participants have enabled cross
sectional and longitudinal studies of age-related and metabolic diseases, and effects of pharmacological interventions.
The emergence of advanced imaging technologies has also created the need for automated image analysis techniques for
identification and quantification of morphological patterns of anatomies and tissues and their changes with increasing
age.
This project will contribute novel and non-invasive medical image analysis techniques for studying the human
body composition to achieve timely diagnosis of these pathologies. Our research interests will concentrate on
identification of morphological patterns in the lower extremity that will eventually lead to development of imaging
biomarkers. We will use imaging and clinical data collected by the Baltimore Longitudinal Study of Aging (BLSA) that
is the longest ongoing epidemiology study in the US, as well as publicly available datasets. We will build on recent
advances in medical image analysis to contribute novel and non-invasive techniques for studying the human body
composition and its changes (aim 1). Then we will develop machine learning methods for timely diagnosis and prognosis
of metabolic and age-related diseases (aim 2). We will implement these techniques as open-source software for further
use and development by the research community (aim 3).

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Makrogiannis, Sokratis Narrative Age-related and metabolic diseases, such as type-2 diabetes, cardiovascular diseases, sarcopenia, osteoporosis, and osteoarthritis, have become a worldwide epidemic, and affect the quality of life of millions. To give a global perspective, roughly 343.8 million people in the world have type-2 diabetes today, and 175 million don’t know they have diabetes at all. This project will contribute novel and non-invasive medical image analysis techniques for studying the human body composition and its changes with increasing age, to achieve timely diagnosis of these pathologies. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page